Epigenetic Regulation of Breast Cancer Progression by the Proto-oncogene PELP1

DESCRIPTION (provided by applicant): Breast cancer is the second leading cause of cancer death in women. Estrogen and its target estrogen receptor alpha (ERα), a master transcriptional regulator, are implicated in the initiation and progression of breast cancer. Endocrine therapies using tamoxifen and aromatase inhibitors substantially improve disease- free survival, however, initial or acquired resistance frequently occurs. While the molecular mechanism by which tumor cells modulate epigenetic changes at ERα target genes remains elusive, the deregulation of epigenetic modifiers may contribute to oncogenesis and therapy resistance. As a consequence, there is a critical need to understand the molecular mechanism(s) by which deregulation of epigenetic changes occurs during breast cancer progression. The transcriptional functions of ERα are influenced by several coactivators, including PELP1 and CARM1, that associate with histone modifying activities. PELP1 is an ERα coregulator and proto-oncogene with aberrant expression in hormone-related cancers and is an independent prognostic indicator of decreased survival in breast cancer patients. The molecular mechanism by which PELP1 promotes oncogenesis is not completely understood. My preliminary findings suggest that (1) PELP1 has the ability to recognize arginine di-methyl modified histone H3; (2) PELP1 interacts with the histone modifying enzyme CARM1; (3) PELP1 status affects CARM1 recruitment to ERα target genes and (4) PELP1 knockdown affects arginine methylation at ERα target genes. Based on these strong preliminary findings, I hypothesize that PELP1 interactions with CARM1 are crucial for PELP1 oncogenic functions and the PELP1-CARM1 axis determines the arginine methylation code at the ERα target genes leading to breast cancer progression. The objective of this proposal is to characterize the functional interaction of the PELP1 and CARM1 complex and determine the mechanism of epigenetic regulation of breast cancer progression by identifying the target genes and pathways. I will test my hypothesis using two specific aims. In Aim 1, I will test the significance of the PELP1-CARM1 axis in breast cancer by histone methyltransferase, reporter gene, proliferation and migration assays as well as a tumor tissue array. In Aim 2, I will determine the role of PELP1 regulation of the epigenome via arginine methylation by RNA- and ChIP-sequencing as well as ChIP, immunohistochemistry and qRTPCR analysis of murine tissues. Understanding the mechanism by which PELP1 modulates epigenetic changes and the reversible nature of these modifications provides a unique therapeutic opportunity to design novel drugs for treating hormonal cancers.

Public health relevance
The human estrogen receptor (ER) is a key regulator in breast cancer biology. My proposed research is clinically significant, as it will define the mechanisms by which the estrogen receptor coregulator PELP1 modulates epigenetic changes in breast cancer and the reversible nature of these modifications provides a unique therapeutic opportunity to design novel drugs for treating hormonal cancers. The ability to selectively control estrogen receptor target gene activation could provide novel cancer therapeutics.